Protective role of CH25h/25-HC in diabetic kidney disease.

Abstract
Diabetic kidney disease (DKD) is the leading cause of chronic kidney disease (CKD) worldwide. Endothelial cell
(EC) dysfunction is a key event leading to the progression of DKD. Loss of ECs occurs in both glomerular
endothelial cells (GECs) and peritubular endothelial cells (PTECs). Through unbiased screening of GEC
transcriptome in animal models with early DKD, we identified cholesterol 25-hydroxylase (CH25H) as one of
the highly regulated genes in diabetic kidneys. CH25H is the main enzyme that hydroxylates cholesterol to
generate 25-hydroxycholesterol (25-HC). Previous studies have shown that CH25H and 25-HC are involved in
a wide range of biological processes, including regulation of inflammation, lipogenesis, and EC function.
However, these studies reveal controversial findings, suggesting that the exact role of CH25H and its metabolite
25-HC have not been well-defined. CH25H is known to be highly expressed in the kidney cells but its role in
renal cell biology and pathology has never been reported. Over the last several years, we have generated a
large amount of preliminary data to support the critical role of CH25H/25-HC in the pathogenesis of DKD. Our
key observations show that CH25H is expressed mostly in GECs and PTECs and that its expression is
increased in human and mouse kidneys with early DKD. Global deletion of CH25H in db/db mice aggravated
DKD and was associated with increased EC apoptosis, while treatment of db/db mice with 25-HC was able to
alleviate the kidney injury. Mechanistically, we found that 25-HC increased ARF4 activity in ECs by disrupting
the interaction between ARF4 and its inhibitor ASAP1. We also confirmed the key role of ARF4 in the Golgi
function in ECs. We found that in diabetic conditions, ASAP1 expression was increased in ECs and resulted in
ARF4 deficiency, Golgi dysfunction, and EC apoptosis, but these abnormalities could be rescued by
overexpression of CH25H or treatment of 25-HC. An intronic single nucleotide polymorphism of ASAP1 and a
missense mutation of ASAP1 were also identified to be associated with DKD in diabetic patients. Based on
these preliminary data, we hypothesized that CH25H/25-HC has a major protective role in DKD via
maintaining normal Golgi function in ECs by inhibiting the negative regulatory effect of ASAP1 on ARF4.
To test this hypothesis, we propose the following aims: Aim 1: Determine how CH25H/25-HC are regulated in
ECs and how CH25H/25-HC contributes to Golgi dysfunction and EC injury in diabetic conditions. Aim 2:
Determine the cell-specific effects of CH25H on the development of DKD by using inducible EC-specific CH25H
knockout or overexpression mice. Aim 3: Determine the role of ARF4 and Asap1 in the regulation of Golgi
function and EC injury in DKD in mice.

Public health relevance
Project Narrative Diabetic kidney disease (DKD) is the leading cause of end-stage kidney disease in the US and in our veterans. However current regimen provides only partial therapeutic effects and the incidence and prevalence of these diseases remains high, suggesting that the key pathogenic mechanisms driving DKD progression are not adequately inhibited by current treatments. Therefore, there is an urgently need to develop novel therapeutics for DKD patients. The proposed studies may lead to the discovery of novel mechanisms and potential new therapies for DKD.